Functional Analysis of Programmed Genome Rearrangement

My laboratory’s research interests are focused on understanding how changes in genome sequence, structure,
and function arise: both in the context of changes that accumulate over deep evolutionary time and in the context
of changes that occur during the development of cell lineages. An individual’s genome provides a complete set
of instructions for completing development, regulating physiology and passing heritable information to the next
generation. These instructions are encoded in the linear sequence of DNA molecules and are modulated by
epigenetic modifications in the context of higher-order structures. Alterations at any scale can severely impact
an individual’s health or ability to reproduce. It is therefore not surprising that life has evolved a variety of
molecular pathways that contribute to the maintenance of genome integrity. Studying these diverse mechanisms
can provide critical comparative perspective on the cellular, molecular and evolutionary underpinnings of human
genome biology and has the potential to reveal new approaches to modulating related pathways in human.
Following this philosophy, my lab has sought to understand the functional and evolutionary mechanisms that
underlie the remarkable diversity of genome biologies that exist among deep vertebrate lineages. This work
takes advantage of the deep evolutionary history of key vertebrate groups (including lamprey, hagfish and
salamander) and exceptional aspects of their genome biologies (e.g. programmed DNA loss and reprogramming
during development/regeneration) to gain new inroads toward understanding vertebrate genome biology.
Our recent work has largely focused on dissecting the causes and consequences of programmed genome
rearrangement (PGR) in the sea lamprey (Petromyzon marinus). In lampreys, PGR involves changes in the
physical structure (and content) of the genome that occur in a highly predictable and programmatic manner
during early development. These changes result in the reproducible loss of a specific subset of genes from all
somatic cell lineages. In total, ~20% of the lamprey’s genome is eliminated from somatic cells and retained only
by germ cells. Recent progress in this line of research has substantially improved our understanding of the
structure of eliminated chromosomes, allowed us to trace the origins and evolution of eliminated genes, provided
a more integrative understanding of PGR in the context of early embryonic reprogramming, and identified
cellular/developmental pathways that contribute to later stages of PGR. However, the pathways that achieve
initial targeting of sequences for elimination and their differential behavior during cell division remain elusive.
Proposed studies aim to further this line of research address several outstanding challenges with respect to
PGR. These include identification of the pathways that that mediate 1) the targeting of sequences for elimination,
2) the differential migration of eliminated chromatin, and 3) the stable packaging of eliminated DNA. In addition,
our recent work has highlighted the necessity of 4) resolving how PGR integrates with other mechanisms of
embryonic reprogramming that direct the early development of germline and soma.

Public health relevance
Lamprey is a vertebrate that undergoes developmentally programmed genome rearrangements, which result in the reproducible elimination of ~20% of the genome from nearly all somatic cell lineages (this material is retained only in the germline). Our proposed studies will allow us to unravel the mechanisms by which lamprey physically reengineers its genome, and understand how elimination mechanisms are integrated with other epigenetic reprogramming events that define early vertebrate development. If funded, these studies will contribute to our fundamental understanding of cellular mechanisms that contribute to stability and change in vertebrate genome structure as well as gene regulatory changes that mediate the development of germ cells, epigenetic maintenance of pluripotency and oncogenesis. 1